Tissue Repository and Animal Models Core

PROJECT SUMMARY
AML is a highly lethal neoplasm, which is increasing in incidence, and in spite of advances in our
understanding of AML pathogenesis, it is still largely incurable. AML is heterogeneous, with subtypes defined
by clinical, morphologic, cytogenetic, and molecular characteristics. This core provides viable, clinically
annotated, and moleculary characterized primary human AML samples and animal models for mechanism-
based therapeutic studies. Numerous examples of progress from grant years 1-5 have employed these
resources. This Core will pursue the following Specific Aims: Aim 1) Expand, maintain, and characterize
leukemia tissue banks. Data from the Penn State Cancer Institute (PSCI) Bank form much of the progress
described in this application. The Core will be strengthened by the addition of preclinical/clinical isolates from
Memorial Sloan Kettering Cancer Center (MSKCC). Our bank will be expanded through inclusion of clinical trial
specimens acquired from Project 1 (CAV trial) and ECOG. Molecularly profiled samples will be made available
to Projects and Cores for in vitro study and PDX construction (Aim 3). Aim 2) Assess the toxicities and
determine the Maximum Tolerated Dose (MTD) and pharmacokinetics (PK) of agents in vivo. Animal models
for preclinical toxicity (dose escalation, MTD and pharmacokinetics) assessment are in place at PSCI. Results
from this Aim are critical for continued clinical development of therapeutics. Aim 3) Develop and maintain
animal models for testing program-derived therapies. This application and our published studies demonstrate
promising preclinical data acquired in a number of such models. Transplantable human AML cell line models
labelled with luciferase and YFP/RFP grown as NRG xenografts allow in vivo tumor monitoring and provide
rapid readout of anti-AML efficacy (PSCI). Considerable data are provided with these models in this
application. Pre-clinical efficacy data in such models underscore the premise of evaluating ceramide nano-
liposome (CNL), AraC and venetoclax in a phase Ib/IIa clinical trial (Project 1, pre-IND #142902, UVA Protocol
Review Committee Approval #5414, CAV trial). Dr. Levine's (co-investigator; MSKCC) novel genetically
accurate AML models provide state-of-the-art models of molecularly defined AML subtypes. These models will
be critical in defining genetically-driven alterations in sphingolipid metabolism and for testing the efficacy of
Program therapeutic regimens in all Projects (MSKCC). Finally, PDX models with well-defined primary AMLs
will be used to validate findings in NRGS hosts (PSCI and MSKCC). Efficacy of Program therapeutics will be
compared to and combined with clinically relevant standard-of-care (SOC) chemotherapy regimens. In
aggregate, the Animal Modeling and Clinical Resources Core is a unique and state-of-the-art resource which
provides all Projects with animal models and the clinical material needed to translate novel biologic insights
and therapeutics into clinical studies.

Public health relevance
PROJECT NARRATIVE The overall goals of the present project are to study sphingolipid metabolism in AML and to design novel sphingolipid-based therapeutics for the treatment of AML. This Core will serve an essential role for all projects by maintaining a repository of human AML samples with defined clinical outcomes, as well as by developing robust murine models to test the efficacy of the Project’s sphingolipid-based AML therapeutics.